Mentoring in patient-oriented atrial fibrillation and cardiovascular research

PROJECT SUMMARY
This application will provide the Principal Investigator, Dr. Alvaro Alonso, with protected time and other support
to (1) accelerate a successful record of mentoring junior clinical investigators and graduate students engaged
in patient-oriented cardiovascular research; (2) obtain additional training in omics, machine learning, and
mentoring best-practices; and (3) advance Dr. Alonso's ongoing research on the risk factors and mechanisms
contributing to the development of atrial fibrillation (AF). Mentoring activities will build upon the ongoing
involvement of Dr. Alonso in several training programs at Emory University, including an NHLBI-funded
multidisciplinary T32 training grant on cardiovascular health disparities, the research-track Cardiology
fellowship program at the School of Medicine, and the Master of Public Health and PhD programs in
epidemiology at the Rollins School of Public Health. Training will focus on cutting-edge methodological areas in
rapid development, including integration of omic technologies and machine learning in patient-oriented
research, as well as acquisition of skills in academic, research, and clinical mentoring. Finally, this award will
support a research project that extends Dr. Alonso's ongoing work on understanding the factors influencing the
development of the AF substrate, understanding AF pathophysiology, and preventing AF-related outcomes.
The specific aims of this research are: (1) to identify novel AF phenotypes (phenogroups) using extensive
clinical and multi-omic data (“phenomapping”), (2) to discover specific risk factors for the different AF
phenogroups, and (3) to determine associations of AF phenogroups with selected endpoints (stroke, heart
failure, mortality). These research aims will be carried out in the context of the Emory Cardiovascular Biobank,
an ongoing prospective registry of patients undergoing cardiac catheterization in three Emory-affiliated
hospitals currently including approximately 7,000 unique individuals with detailed phenotyping, clinical
outcomes, and multi-omic markers. In summary, the activities proposed in this application will favorably impact
Dr. Alonso's capabilities to conduct cutting-edge and innovative patient-oriented research on cardiovascular
prevention and his ability to perform as a highly qualified mentor for junior clinicians pursuing research on
clinical cardiovascular epidemiology and prevention.

Public health relevance
PROJECT NARRATIVE Despite progress, atrial fibrillation, a common cardiac arrhythmia, remains a major public health program. This award will contribute to advance our understanding of the causes and consequences of atrial fibrillation. In addition, it will support a nurturing environment for the mentoring of junior clinical investigators interested in prevention and treatment of atrial fibrillation and other cardiovascular diseases.